The impact of insulin sensitivity on the potential of metformin to delay age-related inflammation

Inflammatory diseases limit healthspan, defined as the length of one's life spent in good health. We propose an
ancillary study on deidentified samples from a recent NIA-funded trial Antecedent Metabolic Health and
Metformin (ANTHEM) that will define traits of healthy people who would benefit from metformin intervention
before onset of age-related health risks like chronic inflammation. ANTHEM queries an unexpected outcome of
dual interventions of metformin and exercise: metformin improved metabolic health over exercise alone in
overweight/obese insulin resistant subjects, but metformin blunted exercise-mediated improvements in
metabolic health of otherwise similar insulin sensitive subjects. ANTHEM tests the impact of baseline metabolic
health on the effects of metformin monotherapy on insulin sensitivity and skeletal muscle mitochondria by
recruiting overall healthy subjects to address the general paradigm that lifespan enhancers must start prior to
onset of age-related co-morbidities for maximal benefit. The proposed work will add an inflammation arm to
ANTHEM. The primary endpoint of our ancillary study will be cytokine profiles, a bioinformatic combination of
cytokines that revealed a previously unappreciated Th17 profile that naturally develops systemically with age.
This profile is similar to the systemic profile in type 2 diabetes, and thus suggests a mechanistic link between
inflammation and this major challenge to healthspan. Metformin-mediated repair of mitochondrial
bioenergetics, in combination with improved non-mitochondrial autophagy, lowered the Th17 profile in samples
from older subjects. In contrast, metformin lowered IL-10 production by cells from younger subjects, arguably
increasing inflammation. Our unique approach to defining “inflammation” thus clarified mechanisms of
metformin action, while echoing concepts from the exercise study summarized above: metformin may benefit
subjects with sub-clinical health challenges while having a negative effect on healthier people. We will apply
similar approaches to query metformin's effect on inflammation by analyzing deidentified ANTHEM samples to
test the hypothesis that metformin intervention in healthy subjects with naturally low insulin sensitivity reduces
cytokines known to fuel chronic inflammation, by improving mitochondrial bioenergetics and increasing non-
mitochondrial autophagy in immune cells. The secondary hypothesis is that metformin will have either a
negative or no impact on immune cells from highly insulin sensitive subjects. Mechanistic insights into
metformin action on immune cells will be analyzed relative to changes in body composition, aging biomarkers,
glycemic control, and skeletal muscle outcomes collected for ANTHEM. Parallel ex vivo manipulation of
mitochondrial function and autophagy in immune cells will establish cause/effect relationships amongst
metformin, cell physiology, and cytokine profiles. Success with the proposed project coupled with ANTHEM
outcomes will define traits of people who would benefit from preventative metformin, and perhaps more
importantly, to identify those who may be harmed by proactive metformin use.

Public health relevance
Numerous studies support the premise that inflammation rises in aging. Drugs with anti- inflammatory actions such as metformin may promote healthspan, the length of one's life spent in good health, especially if given prior to onset of age-related declines. We will analyze deidentified samples from an NIA-funded clinical trial to test the possibility that baseline insulin sensitivity impacts the ability of metformin to ameliorate pathogenic inflammation.